Project 4: Chimeric Antigen Receptor T Cell Therapy for the Treatment of Acute Myeloid Leukemia

ABSTRACT
There is an urgent and critical need for the development of leukemia stem cell (LSC)-directed therapeutic
approaches for the treatment of acute myeloid leukemia (AML). One such strategy is targeting antigens that
are specific to LSCs but absent from normal hematopoietic stem cells (HSCs). CD371 (CLEC12A, CLL-1),
which is present on mature myeloid cells, has been described as one such targetable disease marker given its
presence on both bulk AML cells and LSCs. Although not ubiquitously expressed on all AML cells, it is
expressed in up to 95% of AML patients, is enriched on LSCs and chemoresistant AML subpopulations, and
most importantly, is absent on HSCs.
We have successfully developed and validated a fully-human CD371-targeted chimeric antigen receptor (CAR)
T cell product which also secretes IL-18. Given that our CD371-targeting motif is entirely human, it is expected
to have reduced immunogenicity and thus minimizes host-mediated CAR T cell-directed immune elimination in
the context of constitutive IL18 secretion. In addition, IL18 secretion is predicted to enhance CAR T cell
persistence and modulation the tumor microenvironment (TME) by increasing and activating immune cell
infiltrates, leading to the induction of an endogenous T cell mediated anti-tumor immune-response capable of
eradicating antigen-negative tumor cell subpopulations.
Our central hypothesis is that CD371-targeted IL18-secreting CAR T cells will lead to eradication of antigen-
positive chemoresistant and LSC subpopulations, and the induction of an endogenous AML-reactive T cell
response that will lead to elimination of antigen-negative disease, without long-term HSC toxicity. This will be
tested in AML patient-derived xenograft models of heterogeneously antigen-positive disease (Aim 1) and a
phase I clinical trial with CD371-targeted IL18-secreting CAR T cells in patients with relapsed/refractory AML
(Aim 2). This effort will therefore assess the safety and efficacy of this novel CAR-T cell approach in both
preclinical and clinical settings, and will also address biomarkers of response and efficacy in numerous
correlative studies (Aim 3).

Public health relevance
NARRATIVE There is a critical need to develop therapies to eliminate leukemia-stem cells (LSCs) as a treatment for acute myeloid leukemia (AML). To this end, we have developed a novel chimeric antigen receptor (CAR) T cell platform targeting CD371, a cell surface marker present on the vast majority of AML cells and LSCs but absent from normal hematopoietic stem cells. We will determine the safety and efficacy of CD371-targeted, IL18- secreting CAR T cells in patient-derived xenografts models and by conducting a phase I clinical trial in relapsed/refractory AML patients.